Host factors regulating HIV latency and reactivation

Our central premise is that HIV transcriptional inhibitors can be used as latency promoting agents (LPAs) in block-and-lock functional cure approaches, aimed at reducing residual viremia during antiretroviral therapy (ART) and limiting viral rebound upon treatment interruption (TI). This hypothesis came about with the discovery of the Tat inhibitor, didehydro-Cortistatin A (dCA)2,3. In in vitro and in vivo models of HIV latency combining ART with dCA accelerated HIV-1 suppression to below the limit of detection and blocked viral rebound upon TI or stimulation with latency reversing agents (LRAs)4. The transcriptional shutdown by dCA resulted in the heterochromatinization and loss of RNAPII at the HIV promoter5. We recently reported on another LPA, the generic drug, Spironolactone (SP). Interestingly this drug degrades the host XPB subunit of the general transcription factor TFIIH6 inhibiting HIV transcription in primary cells from infected individuals and blocking viral reactivation from latency without affecting cellular transcriptomics7. This study is important because it highlights that a host factor can be targeted to silence HIV without affecting cellular viability. In sum, the more knowledge we gain on the interconnectivity between Tat, transcription factors regulatory mechanisms and how these affect nucleosomes positioning around the HIV promoter, the more we can leverage transcriptional regulators as antiviral targets. To identify novel host factors regulating HIV transcription we used a chromatin affinity purification assay together with mass spectrometry (ChAP-MS)8. We identified p32 (ASF/SF2 splicing factor-associated protein) and FUBP3 (Far upstream element binding protein 3) in productively infected ART treated promoters but not in dCA-treated where HIV was silenced; and PHB2 (prohibitin-2) was enriched in dCA treated promoters but reduced in ART only treated ones. These results suggest that p32 and FUBP3 are HIV transcriptional activators while PHB2 is a HIV silencing factor. Preliminary studies confirmed their transcriptional activity on HIV. Here we propose a detailed molecular mechanistic study on how p32 and FUBP3 enhance and how PHB2 inhibits HIV transcription. Understanding their role in pre-initiation complex (PIC) formation, initiation, elongation and nucleosome organization at the latent HIV promoter will be key for developing successful strategies for durable HIV silencing. Strong effects of one or more of these factors will prompt the search for small-molecule modulators. Our overarching goal is to durably silence latent HIV proviruses by driving each into stable heterochromatin where they will remain “locked.” We propose the following aims: 1) Define the roles of p32, FUBP3 and PHB2 in HIV transcription and chromatin structure. 2) Identify protein complexes associated with p32, FUBP3 and PHB2. 3) Investigate p32, FUBP3 and PHB2 dependence on the Tat/TAR circuitry.

Public health relevance
Narrative The goal of this applications is to characterize in detail the mechanism by which three proteins that we discovered to bind to the HIV genome regulate up or down HIV expression. Drugs that can manipulate HIV expression from infected cells have immense potential in functional cure approaches. The more knowledge we gain on the how these host proteins interact with viral proteins and regulate HIV, the more we can leverage host regulators as antiviral targets.